Liver Prlr signaling in metabolic adaptation to pregnancy

Abstract:
Pregnancy is characterized by maternal insulin resistance secondary to maternal weight gain, especially in
the 3rd trimester. Such physiological response serves to spare blood glucose for the fetus. To compensate
for maternal insulin resistance, the body must undergo adaptive changes in energy metabolism to maintain
euglycemia during pregnancy. Maladaptation of maternal metabolism to pregnancy is causative for
gestational diabetes mellitus (GDM), a disease that affects up to 11% of all pregnancies. Critical for metabolic
adaptation to pregnancy is prolactin, a pituitary hormone whose production increases with the progression
of pregnancy. Prolactin acts as a lactogenic hormone to stimulate breast tissue growth and milk production.
Apart from its essential in lactation, prolactin signaling via prolactin receptor (Prlr) regulates maternal
metabolism. Women harboring genetic PRLR variants are associated with heightened risk of GDM. Prlr is
expressed in the liver, but its liver-specific role in regulating maternal metabolism is unknown. This begs the
question as to how the liver undergoes the adaptative changes in hepatic metabolism in the face of maternal
insulin resistance to maintain normal energy homeostasis during pregnancy. To fill in the knowledge gap, we
will conduct an in-depth characterization of hepatic Prlr signaling and determine its contribution to maternal
metabolism. We generated hepatocyte-specific Prlr-knockout (Prlr-KO) mice. We found that virgin Prlr-KO
mice maintained normal metabolism, but pregnant Prlr-KO mice developed GDM, as manifested by glucose
intolerance at gestational day 15.5, a time that is equivalent to the 3rd trimester in humans. The severity of
GDM in Prlr-KO mice was compounded by multiparity, advanced gestational age or increased maternal
adiposity, three independent risk factors for GDM in women. Our data illustrate an unprecedented role of
hepatic Prlr signaling in regulating maternal metabolism. Hepatic Prlr deficiency is sufficient for causing
metabolic maladaptation to pregnancy, resulting in GDM. To decipher the underlying mechanism, we will
delineate hepatic Prlr signaling and characterize hepatic Prlr targets, whose functions are instrumental for
regulating hepatic metabolism in response to gestation. We will determine the mechanism by which hepatic
Prlr depletion impairs maternal metabolism, contributing to GDM. Moreover, we will conduct ex vivo studies
in primary human hepatocytes to validate the clinical significance of hepatic Prlr signaling in regulating
maternal metabolism in response to prolactin. We expect to elucidate the adaptive mechanism by which the
liver evolves to integrate prolactin signaling with glucose and lipid metabolism during pregnancy. Our data
will gain new mechanistic insights into the etiology of GDM and uncover potential new targets for GDM.

Public health relevance
Narrative: Gestational diabetes mellitus (GDM) is manifested by abnormally high blood sugar levels during pregnancy. In the US, about 1 out of 10 pregnant women develops GDM - a medical condition that imposes a significant risk on the health of both mothers and babies. Our goal is to investigate hormonal regulation of glucose and lipid metabolism in the liver by prolactin, a gestational hormone whose production is increased with the progression of pregnancy. Our studies will gain new mechanistic insights into the etiology of GDM.